Investigating the impact of local land use and zoning policies on equitably reducing tobacco retailer availability

PROJECT SUMMARY/ABSTRACT
Given persistent racialized and socioeconomic inequities in neighborhood tobacco retailer availability (TRA),
decreasing TRA is an important intervention for decreasing inequities in tobacco use and tobacco-related
disease. To address inequities in TRA, several cities have implemented licensing-based policies such as
limiting the number of retailers that may possess a license to sell tobacco in a neighborhood. However, local
licensing-based policies may be difficult to implement in states with preemption, which prohibits local
governments from enacting tobacco control policies such as retailer licensing. To date, 14 states preempt local
governments from regulating tobacco retail licensing. Oklahoma (OK) is one of the most comprehensively
preempted states in the nation, and the state has exclusive authority over tobacco retailer licensing. However,
an examination of OK’s statutes reveals that the state does not preempt localities from regulating zoning or
land use. Use-based zoning may be able to reduce TRA by regulating the land (i.e., parcels) where retailers
are permitted or prohibited from selling tobacco products (e.g., residential, industrial). This mixed-methods
study (based in Oklahoma City and Tulsa) will be the first to explicitly evaluate the impacts of use-based zoning
on eliminating racialized and socioeconomic inequities in TRA in a comprehensively preempted state. The two
Specific Aims include: 1) Evaluate the equity impacts of policies that cap the number of tobacco retailers in
certain zones and 2) Engage with local key stakeholders to identify facilitators and barriers to the dissemination
of Aim 1 findings and implementation of zoning-based tobacco control policies. We will use geographic
information systems and spatial epidemiology methods to identify the relationships between specific zones,
TRA, and neighborhood sociodemographic characteristics. We will then simulate policies that limit the number
of tobacco retailers within certain zones and compare changes in observed neighborhood inequities in TRA
(e.g., weakening of inequities; percent and absolute decreases in TRA) pre- vs. post-policy. We will then use a
semi-structured interview guide to explore key stakeholder recommendations for improving the dissemination
of study results and to better understand perspectives on facilitators and barriers to implementing zoning-
based tobacco control policies in OK, focusing on key implementation outcomes. This innovative and equity-
focused study fits within NCI’s mission to “support cancer research across the nation to advance scientific
knowledge and help all people live longer, healthier lives” with the long-term objective to reduce inequities in
tobacco-related cancers. This study is grounded in dissemination and implementation science best practices
and may produce evidence of reductions in TRA and pro-equity effects, which may open the door for a new
suite of policy tools that can promote tobacco control and health equity, especially in preempted states.

Public health relevance
PROJECT NARRATIVE Tobacco use remains the leading cause of preventable death, and racialized and socioeconomic inequities in tobacco use and related diseases persist. Innovative public health policies to reduce neighborhood TRA equitably are needed, especially in preempted states. This study will be the first to evaluate whether use-based zoning tobacco control policies can be intentionally designed to decrease neighborhood tobacco retailer availability equitably: findings from this study may open the door for a new suite of policy tools that can promote tobacco control and health equity nationally.